Integrative Data Analysis of Coping Power: Effects on Adolescent Suicidality

PROJECT SUMMARY/ABSTRACT
Not applicable for this Administrative Supplement application.

Public health relevance
PROJECT NARRATIVE Not applicable for this Administrative Supplement application.